STUDY OF MN RGP120/HIV-1 IN HIV INFECTED PATIENTS WITH 50-500 C4 CELLS/CUBIC MM

The objectives of this study are to examine the immunologic response of HIV-1 infected individuals with CD4<500 cells/mm3 to vaccination with MN rgp120/HIV-1. Specific immune responses to be investigated include: neutralization antibodies formation, HIV gp120 envelope directed antibody formation, HIV-1 specific proliferative and cytotoxic T cell responses.